PHASE I STUDY--ADENO ASSOCIATED VIRUS CFTR GENE VECTOR IN ADULT CYSTIC FIBROSIS

The purpose of this study is to place experimental genes into CF patients to see if this virus will cause the nasal and pulmonary cells to make CFTR protein.